Human vs. Rodent Amyloid-beta Fibrils

We propose to compare the structures of human and rodent (mouse and naked mole rat) amyloid-β (Aβ) fibrils using solid-state NMR. Transgenic mouse models are a mainstay of Alzheimer’s disease research. Many of these models include overexpression of Aβ, with various mixtures of human and endogenous mouse peptides in the different models. Although a great deal has been learned about the structure of human Aβ fibrils, much less is known about mouse Aβ, and species differences between rodent and human Aβ aggregates is underappreciated. This difference, however, could bear importantly on studies of neurotoxicity of Aβ. Some transgenic mouse models include massive overexpression of Aβ, and while this leads to some cognitive impairment, the burden of amyloid deposition seems disproportionately great compared to the neurological findings. There are several possible, non-mutually exclusive explanations for this discrepancy. Here, we propose to study one of them: that mouse and rodent Aβ aggregates differ structurally. It has been amply demonstrated that human Aβ peptides display polymorphism: that is, a single polypeptide can form different fibril structures depending on fibrillization conditions. These polymorphs differ in cyto-/neurotoxicity. Thus, this proposal is guided by the hypothesis that structural differences in mouse and human Aβ aggregates could lead to differences in neurological effects. As a first step in testing this hypothesis, we will compare human and rodent Aβ40 and Aβ42 fibrils. The proposal has two Specific Aims. The first is to compare the structures of Aβ fibrils from mouse, naked mole rat and human peptides using SS-NMR. These peptides differ at several key residues in the N- terminal domain of Aβ. Preliminary data (TEM, NMR) indicate that fibrils from these 3 species (rationale for these choices is given in the proposal), formed under rigorous controlled, identical conditions, adopt different structures. Aim 1 will continue these investigations. The second specific aim is to study and compare the structures of mouse and human brain-seeded Aβ fibrils. We have published several papers on producing “replicate fibrils” for solid-state NMR, by seeding with authentic human brain amyloid from patients who died with Alzheimer's disease. We now propose to apply these methods to compare human and mouse brain amyloid-seeded Aβ40 and Aβ42 fibrils. Future plans are 1) to extend this work, in an R01 application, to a comparison of the cyto-/neurotoxicity of polymorphs directly; and 2) an application of these seeding techniques to examine brain amyloid-seeded soluble oligomers of Aβ peptides.

Public health relevance
This is a proposal to compare human and rodent (mouse and naked mole rat) Aβ40 and Aβ42 (amyloid-β) fibrils using solid-state NMR. Despite the widespread use of transgenic mouse models of Alzheimer's disease, with overexpression Aβ, relatively little is known about the structure rodent Aβ fibrils, and how these differences might relate to neurotoxicity. We will compare polymorphism of human and rodent Aβ fibrils using expressed peptide and brain amyloid-seeded fibrils, and in future work, relate structural differences to possible differences in cytotoxicity.